Investigating the molecular mechanisms of glycosaminoglycan assembly

Title: Investigating the molecular mechanisms of glycosaminoglycan assembly
Project Summary
The long-term goal of this research program is to elucidate and understand the regulatory mechanisms involved
in the biosynthesis of glycosaminoglycans (GAGs) in mammalian cells. GAGs are long, linear polysaccharides
that are expressed on all animal cells and play a key role in many cellular processes, including cell signaling and
development. These complex carbohydrates are typically attached to core proteins, known as proteoglycans,
located on the cell surface and in the extracellular matrix, and the chains are composed of alternating
glucosamine and uronic acid sugar residues that are heterogeneously N- and O-sulfated. The biosynthesis of
GAGs is a non-templated process, driven by the concerted activity of a large family of enzymes localized to the
Golgi and endoplasmic reticulum. The arrangement and orientation of the sulfated sugar residues specify the
location of distinct ligand binding sites on the cell surface, and these modifications can vary temporally during
development and spatially across tissues. The capacity of GAGs to bind ligands impacts the fundamental
properties of cells, the ability to form tissues and organs, and normal physiology. Despite the key functions of
these molecules, there is a significant gap in knowledge regarding the regulatory mechanisms that give rise to
their variable composition and binding properties. Through a multidisciplinary research program that leverages
strengths in functional genomics, cell biology, and glycobiology, we aim to identify and characterize the
mechanisms involved in controlling the inherent diversity of GAG structure and function in cells. Of particular
interest, is the role of chromatin remodeling complexes in regulating GAG assembly during development and in
disease states, as we recently identified members of the polycomb repressive complex (PRC) as novel
epigenetic modifiers of GAG enzyme expression and assembly. We hypothesize that defined epigenetic and
transcriptional programs tune the expression of biosynthetic enzymes in distinct cell types, which modulates their
interaction with a plethora of growth factors and other binding partners in the extracellular matrix. We also aim
to investigate how the core biosynthetic machinery is regulated in situ in the endoplasmic reticulum and Golgi.
We plan to explore the physical association of the biosynthetic enzymes and core proteoglycans in the ER and
Golgi and identify unknown chaperone and/or scaffolding proteins that may tune glycosylation in the secretory
pathway. To carry out this work, we will leverage our historic strengths in the analysis of GAG structure, function,
and regulation to understand: (1) how transcription factors and chromatin remodeling complexes control the
expression of GAG biosynthetic enzymes, which impacts GAG structure and function, (2) how protein-protein
interactions in the ER and Golgi orchestrate proteoglycan assembly in distinct cell types, and (3) how
proteoglycan core proteins act as scaffolds for GAG assembly. Overall, we expect this endeavor to significantly
advance our knowledge regarding the regulatory mechanisms controlling glycosylation and offer new strategies
and targets to manipulate GAG biogenesis in human disease.

Public health relevance
Project Narrative Glycosaminoglycans are linear polysaccharides that are expressed on all animal cells and play a key role in cell homeostasis and have been implicated in many human diseases, including cancer, pathogen infection, and developmental disorders. This proposal describes strategies utilizing functional genomics, biochemical techniques, and proteomics to determine the molecular mechanisms that control glycosaminoglycan assembly, which are virtually unknown. Regulatory mechanisms identified in these studies will shed light on the biosynthesis of these complex carbohydrates in normal physiology and disease states and may provide novel therapeutic targets for human disorders.